Adaptive Immune Receptor Repertoire (AIRR) Community Meeting 2021

The central aim of this re-submission is to convene a meeting of the Adaptive Immune Receptor Repertoire
Community (AIRR-C) in December of 2021. The PI of the proposal, Dr. Lindsay Cowell, who is now the
Chair of the AIRR-C's Executive Sub-committee (SC). The submission of this proposal was undertaken in
close collaboration with the Members of the AIRR-C Meetings SC. A given AIRR comprises the antigen
receptors on a population of T cells (TcRs), B cells (BcRs) and/or the antibodies (Abs) secreted by plasma-
blasts and cells, and reflects the clonal composition of such populations. With the advent of high-throughput
DNA sequencing, the AIRR-C emerged as a grass roots, multidisciplinary and inclusive scientific community
dedicated to the development of methods and standards for the generation, analysis, storage and sharing of
AIRR sequencing (AIRR-seq) data and its associated metadata, following FAIR-data principles and open-
science practices. The 2020 meeting is the fifth AIRR-C meeting and will be held at Scripps Research in
partnership with our Scripps host, Dr. Dennis Burton, and next door at the La Jolla Hilton hotel, on 8-11
December 2021. The Members of the AIRR-C Meetings SC comprise 3 women and 3 men at all stages of
career from grad student to full professor, and from 6 different countries; their immunological expertise
spans a wide range from immunogenetics to cellular immunology, bioinformatics and computational
sciences. Together, they have prepared an exciting meeting with two Scientific sessions presented by 8 top
scientists in their field, covering current advances made with AIRR-seq data in the Basic and Biomedical
Sciences. And, to advance the AIRR-C's goals, two Challenge Sessions are planned to explore
“Sustainability for the AIRR-C and its Mission” (a panel discussion) and the relevance of AIRR-seq data to
“Systems Immunology” (with presentations by 4 outstanding scientists). As detailed in the proposal and
letters of support, the meeting will provide opportunities for investigators and trainees to network, participate
in AIRR-C Working Groups and learn in hands-on tutorials, poster presentations and platform presentations
and advance the field of immune-repertoire profiling. The AIRR-C Meetings and Executive SCs have taken
NIH's new requirement for a diversity plan to heart, and will commit the requested funds to providing travel
and lodging support for two types of attendees from under-represented groups: (i) early-career scientists
and their trainees, and (ii) attendees from local universities that support under-represented students (e.g.,
Charles Drew University in LA, the local Cal State Universities in Southern California). This plan includes
outreach to these institutions, and a description for how early-career scientists, trainees and other students
could become active participants within our scientific networks as members of our 7 Working Groups and/or
2 SCs. This conference is meant to provide a deep learning experience for all and a chance to strengthen
our scientific networks; this is a proven approach to stimulating collaborative advances in biomedicine.

Public health relevance
Project Narrative The proposed meeting of the Adaptive Immune Receptor Repertoire Community (AIRR-C) is aims to: (i) strengthen collaborations within and outside its scientific networks, (ii) attract and mentor early career investigators, trainees and interested students to participate in its Working Groups and networks, and (iii) to reach out to potential participants in under-represented groups, both nationally and internationally. In strengthening our networks and diversifying perspectives within them, this AIRR-C meeting will help advance the collaborative research, the burgeoning FAIR data principles and open-science practices that will be key to future advances in “the big-data” areas of immunology and related biomedical sciences.